iPSC-derived VSMC for high-throughput screening of small molecules for aortic aneurysm

Aortic aneurysms (AA) are abnormal aortic dilatations, which remain clinically silent until, inevitably, the
aortic wall dissects or ruptures. High blood pressure and genetic mutations in components of the arterial
wall are major risk factors, such as mutations in the fibrillin-1 gene in Marfan syndrome. We recently
demonstrated that sirtuin-1 (Sirt1), a deacetylase important for cells to cope with metabolic and
inflammatory stressors, can be oxidatively modified on critical cysteine thiols nearby its catalytic site;
these oxidative modifications inhibit Sirt1 activity, increasing matrix metalloproteinase (MMP2/9) activity
and associated elastin fragmentation leading to aortic aneurysm and dissection in Marfan syndrome.
Notably, mutating these cysteines, which rendered the mutant Sirt1 resistant to oxidations, restored
Sirt1 activity and decreased MMP2/9 activity in vascular smooth muscle (VSMCs) from Marfan mice.
Based on this compelling scientific premise, we hypothesize that targeting oxidized Sirt1 could become
a novel therapeutic approach to prevent AA and aortic dissections in Marfan syndrome. Through in silico
docking analysis and rational drug design of a molecular library comprised of >4,000 compounds, we
have identified a lead series of small molecules that showed efficacy in activating Sirt1 in preliminary
studies, even in oxidative stress conditions. We will assess the efficacy of our novel class of Sirt1
activators, structurally and mechanistically different than previously developed Sirt1 activators, in
inhibiting MMP2/9 hyperactivation and inflammation (VCAM1, p65-NFB) in Marfan VSMCs. We will
also generate induced pluripotent stem cell (iPSC)-derived VSMCs, a clinically relevant in vitro model
on which to test our small molecules, using peripheral blood mononuclear cells from Marfan patients
obtained from the GenTAC/BioLINCC biorepository. These studies are a crucial first step to advance
our molecules to in vivo studies and further drug development. If successful, our small molecules Sirt1
activators can become a novel therapy to prevent AA and aortic dissections in individuals at risk, such
as Marfan syndrome and related disorders, for which currently no targeted therapy has been developed.

Public health relevance
Despite our understanding of genetic and molecular cues behind aortic aneurysm and dissection in Marfan syndrome, targeted therapies are still critically lacking. Using rational drug design, we identified a lead series of compounds that showed efficacy in activating sirtuin-1, an enzyme we demonstrated becomes inactive in aortas and vascular smooth mucle cells of Marfan individuals and animal models. We will assess the efficacacy of these small molecules in activating sirtuin-1 and its downstream targets using in vitro systems, including vascular smooth muscle cells from Marfan individuals, which we will generate from peripheral blood cells via pluripotent stem cell reprogramming.